Administrative Core

The Administrative Core for WV-INBRE will be responsible for (1) overseeing the growth and
development of the biomedical research network, (2) providing biomedical research opportunities,
mentoring and training for network faculty and students, and (3) providing day-to-day logistical
support to the WV-INBRE network and the External Advisory Committee (EAC). The AC will be
composed of the PI (Dr. Gary Rankin, Marshall University (MU)), the PC (Dr. Stan Hileman, West
Virginia University (WVU)), the Data Science Core Director (Dr. James Denvir, MU), the
Sequencing, Molecular and Related Technologies (SMART) Core Director (Dr. Travis Salisbury,
MU), Summer Research Program Director (Dr. Elsa Mangiarua, MU), Evaluation Coordinator (Dr.
Nalini Santanam, MU), Mentoring Coordinator (Dr. Andrew Shiemke, WVU), the WV-
INBRE/HSTA Coordinator (Valerie Watson, WVU), the Faculty Research Development Program
Coordinator (Dr. Werner Geldenhuys, WVU), the Tracking Coordinator (Dr. Piyali Dasgupta, MU)
and the Diversity and Inclusion Advisor (Dr. Shelvy Campbell, MU). The AC will work with the
Steering Committee to ensure that WV-INBRE adheres to its mission in building research capacity
in network institutions and that network institutions fulfill their commitments to their faculty and
students. The AC will work with the Executive Committee to develop strategies for interacting with
the EAC and help oversee the development of workshops, webinars, etc., review progress of the
major PUI research projects, and work with the Evaluation Coordinator to determine the impact
of WVINBRE on the development of the primarily undergraduate institutions (PUIs) and Project
Investigators. The EAC will be composed of five members, who will attend all EC meetings and
provide evaluation, guidance and assistance in project review and selection. Members of the AC
will direct the Data Science and SMART Cores and Developmental Research Project Program.
Dr. Mangiarua, with assistance from Drs. Geldenhuys and Shiemke, will oversee the summer
research program to provide summer research opportunities to PUI students and faculty. Dr.
Santanam will coordinate all evaluations (internal and external; formative and summative) of the
WV-INBRE program. Dr. Shiemke will oversee mentoring of network investigators and help match
PUI researchers with appropriate mentors. Ms. Watson will coordinate the highly interactive WV-
INBRE – Health Sciences and Technology Academy (HSTA) initiative. HSTA is a NIH Science
Education Partnership Award (SEPA) program that focuses on minority and disadvantaged high
school students, involving them in STEM and biomedical research projects. Dr. Geldenhuys will
oversee the Faculty Research Development Program, which provides pilot funding, travel funds
and equipment grants to the PUI investigators. Dr. Dasgupta will coordinate tracking of the
students who participate in WV-INBRE sponsored research projects, and Dr. Campbell will advise
the leadership on all aspects of enhancing diverse perspectives in WV-INBRE.

Public health relevance
The Administrative Core (AC) of WV-INBRE is a highly interactive Core for administering the day-to-day operations of the network, developing research network components and providing support for the research network. Through the interactions of the Steering and Executive Committees working with WV-INBRE leadership and input from the External Advisory Committee, the AC will oversee and grow biomedical research infrastructure and capacity across West Virginia.